iLookOut for Child Abuse: Microlearning to Improve Knowledge Retention

The epidemic of child abuse in the U.S. (>670,000 confirmed annually) causes massive harm to children and the
adults they become. Surprisingly, <1% of these substantiated cases of child abuse are identified and reported by
early childhood professionals (ECPs) –despite the fact that ECPs take care of >10 million American children,
and that infants and toddlers account for >75% of all deaths related to child abuse.
Results from our parent randomized controlled trial show that the online iLookOut for Child Abuse (iLookOut)
Core training significantly improves ECPs' knowledge and attitudes about child abuse/reporting (effect size=1.09
and 0.66, respectively). Preliminary data from this trial also suggest that (compared to standard training)
iLookOut improves ECPs' actual reporting of suspected abuse: i) reports are more likely to be screened-in for
investigation by child protection services (86% vs 70%, p<.001), and ii) these screened-in reports are more likely
(56% vs 34%, p=.001) to be “high yield” (ie, child abuse is identified and/or social services are recommended).
But we know that for gains to be sustained, they must be reinforced …and reinforced again. This is because newly
acquired knowledge and habits decay over time unless they are kept in use. Built into the design of our parent
study was an exploratory effort to deliver basic, ad hoc follow-up messaging to maintain awareness and promote
knowledge retention after completing iLookOut's Core training. But it was beyond the scope of the parent study
to fully develop this follow-up intervention, study its impact, or establish its optimal timing.
Through several small grants, we built a research-quality platform to deliver brief (5-10 minute) gamified micro-
learning activities that reinforce and augment what is taught in iLookOut's Core training, and provide practice
opportunities to apply what has been learned. We have piloted this micro-learning in the parent study and shown
that ECPs will complete these activities on their smart phones in return for 3 hours of (no cost) professional
development credit. This, along with strong evidence for the efficacy of iLookOut's Core training, now positions
us to systematically examine how interactive, gamified micro-learning promotes knowledge retention and fosters
behavior change (regarding child abuse and its reporting), and to establish that its implementation is feasible.
Just as rigorous research is needed to determine the optimal timing to give booster doses of vaccines to bolster
a child's immunity, it is likewise essential to understand the optimal timing for administering iLookOut's micro-
learning so as to boost ECPs' waning knowledge/preparedness to protect children from abuse. Using validated
measures, self-report, and data from state child protection services, this study will 1) measure the rate of
knowledge decay following iLookOut's Core training, 2) examine how well micro-learning activities (delivered at
variable time points) promote knowledge retention and behavior change regarding child abuse and its reporting,
and 3) establish whether iLookOut's micro-learning (as a follow-up to Core training) offers an implementation
strategy that is feasible (ie, well-accepted, appropriate to the task, and sustainable).

Public health relevance
This renewal application proposes to conduct a randomized controlled trial to examine how interactive, gamified micro-learning promotes knowledge retention and fosters behavior change with regard to child abuse and its reporting, and to establish that implementation of this intervention is feasible. After completing the online iLookOut for Child Abuse Core training, early childhood professionals will receive brief (5-10 minute) gamified learning exercises that they can complete on their smart phones or computers. These micro-learning exercises are designed to promote skill-building, provide opportunities to practice decision-making, reinforce learning and behavior change, and be easily and sustainably implemented.